Addressing appetitive traits to promote weight management in children who overeat

ABSTRACT
Approximately 35% of children in the U.S. have overweight or obesity (OW/OB). To date, the most successful
weight loss program for children is Family-Based Treatment (FBT), which is delivered to both children and
parents and includes nutrition and physical activity education, behavior therapy techniques, and parenting
skills. Data suggest that 2/3 of children who participate in FBT do not respond. This lack of success suggests
that there are unaddressed mechanisms that could be impacting treatment response. The Behavioral
Susceptibility Theory purports that food cue responsiveness (FR) is the primary driver of eating onset, while
satiety responsiveness (SR) is the primary driver of eating offset. High FR is a risk factor that influences weight
loss maintenance among children who participate in FBT. We developed a new model for the treatment of
children with OW/OB, called Regulation of Cues (ROC), which is based on the Behavioral Susceptibility
Theory. The ROC program targets these mechanisms for overeating, by focusing on reducing FR and
increasing SR. We pilot tested the ROC model with children who overeat with OW/OB, and showed that the
ROC program is feasible, acceptable and is a promising treatment for children. The objective of this proposed
study is to further evaluate the ROC program among children with OW/OB who are high on FR and their
parents. We propose a multisite 4-arm randomized controlled trial at UC San Diego and University of
Minnesota that will compare ROC, FBT, ROC+ nutrition education and caloric restriction (ROC+) and a health
education comparator (HE) over 18 months. We will recruit and randomize 280 children with OW/OB who are
high on FR and their parents and will conduct assessments at baseline, throughout treatment, post-treatment,
and at 6- and 12-month follow-up. The primary aim of this study is to evaluate changes in child weight
(BMIz/%BMIp95) as well as overeating episodes among children enrolled in ROC, FBT, ROC+ and HE.
Secondary aim 1 will compare ROC, FBT, ROC+ and HE on child SR, FR, inhibition, and energy intake over
the course of the treatment and follow-up. Secondary aim 2 will compare ROC, FBT, ROC+ and HE on parent
outcomes, including weight loss (BMI), overeating episodes, satiety responsiveness, food cue responsiveness
inhibition, and energy intake over the course of treatment and follow-up. Finally, exploratory aim 1 will evaluate
effects of mediators (food cue responsiveness, satiety responsiveness, inhibition) and moderators (food cue
responsiveness, satiety responsiveness, demographics, baseline BMIz/%BMIp95/BMI) of treatment effects on
weight loss over time among children and parents. This study could provide a more durable weight loss
program for children with OW/OB and high FR and has the potential to change the paradigm of weight-loss
treatment for children. This study will also contribute to the study of basic appetitive mechanisms and food
intake and inform clinical decision making for children with OW/OB.

Public health relevance
NARRATIVE Family-based treatment (FBT), the current gold standard for program for child weight management, is not effective for children who are high on food cue responsiveness, a risk factor for weight regain. This application tests a novel model that targets appetitive traits, called Regulation of Cues (ROC), and compares ROC to FBT, ROC + nutrition education and caloric restriction, and a health education comparator. Results of this study could provide a more potent and durable model for the treatment of children with overweight or obesity who are high in food cue responsiveness and can inform clinical decision making.